Training and Dissemination

TRAINING and DISSEMINATION
SUMMARY
The investigators of this National Center for Biomedical Imaging and Bioengineering (NCBIB) are dedicated to
providing training in the biomarker tools that will be developed based on novel advanced brain imaging and
spectroscopy acquisition and analysis techniques. This includes training of external collaborators through
conferences, workshops, tutorials, and local lectures and training of internal collaborators, postdoctoral fellows
and students on site. We will also have training at the resource for lab members of external collaborators or
users as well as training of external collaborators through site visits. In addition, we will provide training through
web (e.g. zoom) and email communications and on-line tutorials.
We are also committed to the prompt and widespread dissemination of research results and technological
advances. Dissemination involves (A) publication of peer-reviewed papers in scientific journals, books, book
chapters, and special issues of journals; (B) Lectures at local, national and international conferences,
workshops, and seminars and organizing such meetings; (C) maintaining a Resource website; (D) distributing
acquisition and analysis tools and software to universities and hospitals; (E) transferring technologies to
industry
For this new NCBIB we intend to continue our successful training and dissemination practices built up over the
20 years from our previous P41 and expand upon them using newly available technologies such as web-based
meetings.